The Role of IMAT Inflammatory Secretome on Muscle Insulin Resistance

PROJECT SUMMARY/ABSTRACT
Skeletal muscle insulin resistance with type 2 diabetes (T2D) is, in part, caused by adipose inflammation and
endocrine signaling. Intermuscular adipose tissue (IMAT) is a particularly problematic adipose depot as it resides
under the muscle fascia and between myofiber bundles. Thus, it is uniquely situated for paracrine-mediated
signaling towards muscle. Total IMAT content and its pro-inflammatory transcriptome relate to insulin resistance
in humans, with the obese IMAT secretome milieu inhibiting myotube insulin sensitivity in vitro. However, it is
unknown if the pro-inflammatory IMAT secretome is dynamic, contributing to muscle insulin resistance with
obesity and T2D. There is a critical need to address this gap in knowledge in order to provide the framework for
interventions to minimize IMAT-induced muscle metabolic dysfunction. The overall objective of this project is to
quantify the IMAT secretome across BMI and insulin sensitivity and evaluate the importance of mitogen-activated
protein kinase (MAPK) signaling in IMAT-induced muscle insulin resistance. We will utilize IMAT from the vastus
lateralis of individuals with obesity or obesity and prediabetes/T2D in comparison to lean controls through a
currently funded R01 (under the sponsor Dr. Bryan Bergman) to achieve the following specific aims. Aim I:
Evaluate the extent to which intermuscular adipose tissue pro-inflammatory secretion differs across BMI
and insulin sensitivity in humans. Based on our preliminary evidence that IMAT with obesity has a more potent
pro-inflammatory secretome compared to other adipose depots, our hypothesis is that IMAT secretome scales
to BMI and insulin resistance. A high-throughput quantitative proteomic assay will measure inflammatory proteins
in IMAT conditioned media. Aim II: Elucidate the importance of MAPK signaling in intermuscular adipose
tissue-induced skeletal muscle insulin resistance. Our preliminary evidence demonstrates that obese IMAT
paracrine milieu upregulates c-Jun N-terminal Kinase (JNK1) and p38 activity, and downregulates insulin
sensitivity, in human myotubes. Our hypothesis is that inhibition of MAPK signaling will help to alleviate IMAT-
induced muscle insulin resistance. This will be tested by evaluating IMAT conditioned media-induced insulin
resistance with either JNK1 or p38 inhibition through either viral siRNA knockdown or pharmacological inhibition
in human myotubes. Our expected contribution is significant because IMAT is positioned as a strong candidate
to explain the pathology of muscle insulin resistance that is central to T2D. This training plan includes
sponsorship by Dr. Bergman at the University of Colorado Anschutz Medical Campus (CUAMC). The proposed
research will enhance the skillset of the postdoctoral fellow in both clinical and in vitro methods. The postdoctoral
fellow will complete additional training in endocrinology, obesity metabolism, and biostatistics through the
Nutrition Obesity Research Center and Clinical and Translational Sciences Institute at CUAMC. This research,
sponsor, and institution will collectively position me as an independent translational scientist investigating the
role of skeletal muscle insulin resistance in T2D risk and progression.

Public health relevance
PROJECT NARRATIVE The proposed research aims to reveal (I) the dynamics of intermuscular adipose (IMAT) pro-inflammatory secretome across the BMI and insulin sensitivity spectrum and (II) the relative contribution of MAPK signaling to IMAT-induced muscle insulin resistance. This is relevant to public health because IMAT is physically positioned to exert profound metabolic consequences on skeletal muscle. Our findings will align with the NIH mission by enabling targeted IMAT therapies to robustly sensitize muscle to insulin, thus enhancing health, lengthening life, and reducing disability.